High Accuracy Nanopore Sequencing

This project is an expansion of the scope of our current funding which was awarded to improve nanopore sequencing. In the course of our research to improve nanopore DNA sequencing, we have discovered and developed a new high-resolution single-molecule tool to observe the motion of helicases and polymerases. The tool, which we called Single-molecule Picometer Resolution Nanopore Tweezers (SPRNT), is able to reveal the single-nucleotide steps of helicases and polymerases at unprecedented detail. These enzyme steps are so small (~0.3 nm) and fast (~ 1 ms) that no other existing single-molecule technique can resolve such motion in real time and at physiological conditions. The genome of the SARS-CoV-2 virus encodes for an RNA-dependent RNA polymerase, also known as non-structural protein 12 (nsp12), and a superfamily 1B helicase, known as nonstructural protein 13 (nsp13). Both of these enzymes are essential and specific to the in vivo replication of many viruses, making this genomic replication machinery an ideal drug target. Several drug candidates to inhibit these enzymes exist, however, none are as effective as they need to be to stem the tide of the current pandemic. Many questions remain about how exactly these drugs interfere with the function of nsp12 or nsp13. SPRNT provides an opportunity to answer these questions. We aim to use SPRNT to analyze the single-molecule motion of nsp12 and nsp13 in physiological conditions and in the presence of drugs against them. The exact knowledge of the mechanisms by which various drugs inhibit nsp12 or nsp13 will enable more rational and rapid design of effective antiviral drugs that have the potential to stop COVID-19.

Public health relevance
Project Narrative In the course of our NHGRI funded research to develop and improve nanopore sequencing of DNA we discovered an unprecedentedly precise single-molecule tool that allows us to understand and optimize helicases and polymerases as they pull nucleic-acid through the nanopore. Here we propose an expanded set of aims to use this new tool on the helicase and polymerase that SARS-CoV-2 encodes. This research will provide an opportunity to more rationally and more rapidly develop effective antiviral drugs that stop COVID-19.